Artificial Intelligence, Modeling, and Informatics for Nutrition Guidance and Systems (AIMINGS) Center

The United States Military Academy (USMA) will implement computational and data science approaches and tools to advance nutrition for precision health in a way that accounts for the complex systems involved, in support of the NIH Nutrition for Precision Health powered by the All of Us Research Program (NPH). The work will be done as part of the Artificial Intelligence, Modeling, and Informatics, for Nutrition Guidance and Systems (AIMINGS) Center in collaboration with researchers at the City University of New York (CUNY) and the NPH Consortium of awardees, IAW the proposal submitted to the NIH (1-U54TR004279-01) and negotiated milestones for technical tasks as agreed upon by both parties. As part of the NPH AIMINGS Center, the USMA will be responsible for Project 1, a Data Systems Core, and a Computational Systems Core. Through Project 1, USMA will develop and utilize The Data Distiller for Precision Nutrition, a set of approached and tools that can collapse and distill nutrition-relevant data to create datasets that are AI-ready and ready for a range of other analyses. The Data Systems Core (DSC) will leverage the substantial computing resources of CUNY, West Point, and the Department of Defense to create a flexible cloud-based architecture for data flow and a collaborative workspace. The Computational Systems Core will provide resources and personnel to support the DSC and tool development/deployment.